B2036 PEG IN TREATMENT OF ACROMEGALY

The purpose of this study is to determine the safety and efficacy of twelve weeks of B2036-PEG therapy at three different daily dose levels in patients with acromegaly. B2036-PEG is a recombinant protein similar to human Growth Hormone (hGH), however, several mutations have been made to alter its binding to the hGH receptor. These changes allow this compound to act as a competitive hGH receptor antagonist. The study will determine the safety and efficacy of B2036-PEG in the short-term treatment of acromegaly.